Biostatistics and Bioinformatics Core

Project Summary – Biostatistics and Bioinformatics Core (Core B)
As described in the application, this P01 Program Project proposal seeks to gain a functional and mechanistic
understanding of the connections between a ketogenic diet and long-term impact on life and health span
outcomes as well as Alzheimer's disease. The breadth and depth of the proposed Program Project, and its
particular needs for state-of-the-art analytic approaches that address longitudinal, high-dimensional, and
integrative treatment of data on both phenotype and genotype, require advanced statistical expertise with a
high degree of specialization. The Biostatistics and Bioinformatics Core will provide comprehensive, tailored
statistical support for research to the needs of the individual projects and cores at all stages of the research
process throughout the life of the Program Project, including study design, protocol development, specified
data analysis, and interpretation of the results to ensure scientific rigor to achieve robust and unbiased results.
The Biostatistics and Bioinformatics Core will also facilitate interactions between all projects and cores by
providing database support in efforts to unite investigators and promote the research progress. The
Biostatistics and Bioinformatics Core will achieve our objectives through three specific aims: 1) provide tailored
statistical support to investigators and projects; 2) develop new statistical methodology for cutting-edge
projects; 3) provide and maintain database support for data sharing. In total, the Biostatistics and
Bioinformatics Core is essential to provide ready access to statistical resources and expertise necessary for
the analytic challenges in the research projects and cores. The Biostatistics and Bioinformatics Core, jointly
with the Administrative Core, will maintain a website to promote communication among researchers across the
Program Project and with the scientific community.